Host Defense Training in Allergy and Infectious Diseases

DESCRIPTION (provided by applicant): The Division of Allergy and Infectious Diseases at the University of Washington has trained 115 physician-scientists through continuous funding provided by this training grant since its inception in 1976. More than 85% of these trainees remain in research positions. Many have achieved leadership positions such as two that became Deans of Medicine, one that became a Department Chair, 7 that became Division Heads, and 17 others with leadership positions. Trainees that have completed in the past 10 years have had remarkable early success in research careers, including >75% achieving research funding, >50% with K awards, and >90% publishing one or more papers related to their supported research. The continuing objective of the program is to provide post-doctoral training for physician-scientists committed to an academic career in infectious diseases, with particular emphasis on research training. Each trainee selects a mentor for detailed research training in one of six research tracks. All trainees complete a core curriculum consisting of required didactic, research and clinical activities. Many trainees elect to take course work at the University of Washington and an average of two a year seek a MPH or MSc award. The program generally requires three years of training, two of which are supported by this training grant. PUBLIC HEALTH RELEVANCE: Infectious diseases continue to extract a considerable social and financial toll even in developed countries due to factors such as emerging pathogens, AIDS or other immuno-compromising conditions and antimicrobial resistance;in fact, they represent the leading cause of morbidity and mortality worldwide. The training of new scientists-physicians who can elucidate the basic mechanisms of host defense is critical for the formulation of new and improved strategies to diagnose, treat and prevent infectious diseases.

Public health relevance
Infectious diseases continue to extract a considerable social and financial toll even in developed countries due to factors such as emerging pathogens, AIDS or other immuno-compromising conditions and antimicrobial resistance; in fact, they represent the leading cause of morbidity and mortality worldwide. The training of new scientists-physicians who can elucidate the basic mechanisms of host defense is critical for the formulation of new and improved strategies to diagnose, treat and prevent infectious diseases.